Identification of novel phosphodiesterase (PDE)-modulating compounds and characterization of associated cytoprotective pathways in lightdamagedretina

PROJECT SUMMARY
Cyclic nucleotide phosphodiesterases (PDEs) are a class of enzymes ubiquitously expressed in the human body,
and they play a critical role in a broad range of physiological processes, including regulation of the immune
system, cardiovascular function, metabolism, reproduction, neurobiological processes of learning and memory,
and vision. PDEs function enzymatically to hydrolyze intracellular cyclic nucleotide second messengers (cAMP
and cGMP), thereby affecting various downstream cellular signaling pathways that control homeostatic
processes. These include repair mechanisms that promote cell survival (somatic maintenance), as well as pro-
apoptotic mechanisms that result in cell death. In aging and disease, dysregulation of these signaling networks
can lead to a reduced investment in somatic maintenance, resulting in pathophysiological states of disease.
However, as key regulatory nodes that modulate intracellular and subcellular concentrations of second
messenger signaling molecules, it is conceivable that PDEs could be pharmacologically targeted in order to
upregulate pathways that improve cellular viability in disease states. By integrating recent advances in PDE
biology with high-throughput methods, this proposal aims to identify new PDE-targeting agents and further
characterize the pathways through which they alleviate pathophysiology in chronic, debilitating disease.
Specifically, our focus will be on the application of newly identified therapeutic agents to ameliorating disease in
a mouse model of retinal degeneration. Our long-term goal is to obtain a better understanding of the role played
by PDE-dependent signaling pathways in the pathogenesis of retinal degeneration and to develop interventions
that stop the progression of human blinding diseases.
Accordingly, we propose three thematically and experimentally linked Specific Aims, to: 1) identify novel PDE-
modulating compounds through in silico screening, 2) evaluate the therapeutic efficacy of PDE-selective
inhibitors in preventing retinal degeneration, and 3) validate a systems pharmacology approach to optimizing
PDE inhibitor therapy. Successful completion of Aim 1 will result in the discovery of novel compounds that
circumvent the limitations of existing PDE inhibitors and exhibit superior targeting selectivity with enhanced
potential for clinical utility. Through completion of Aim 2, we intend to demonstrate a statistically significant
therapeutic effect conferred by PDE inhibition that is robustly conserved across different mouse models of retinal
degeneration. Lastly, successful completion of Aim 3 will dissect the underlying molecular mechanisms of
cytoprotection in the context of stress-induced retinal degeneration, thereby providing innovative systems biology
insights on the synergism between intersecting networks involving crosstalk among the many different cell types
in the retina. Indeed, these insights will facilitate a more unified perspective to attain our long-term goal of
developing new and improved pharmaceutical interventions to combat human blindness.

Public health relevance
PROJECT NARRATIVE Currently, more than 15 million people in North America suffer from age-related macular degeneration (AMD), and the overall prevalence of this disease is projected to increase by over 50% by the end of 2020. The pathogenesis of AMD causes irreversible blindness, and there are currently no effective treatment options for the most common (nonexudative or “dry”) form of the disease. Therefore, this proposal aims to open new therapeutic avenues for the treatment of AMD, by identifying novel phosphodiesterase-modulating compounds and characterizing the signaling pathways through which they exert their cytoprotective effects in the context of retinal degeneration.